High-resolution diffusion imaging of brain connectivity in healthy aging and Alzheimer's disease

PROJECT SUMMARY
Declines in fluid, speed-dependent cognition (e.g., attention and memory) are a hallmark feature of Alzheimer’s
disease (AD), but some degree of decline is also seen even in healthy older adults. Based on magnetic
resonance imaging (MRI) studies using diffusion-weighted imaging (DWI), the cortical disconnection theory
proposes that normal age-related cognitive decline is at least partly explained by the degradation of white
matter pathways connecting distributed brain regions, with greater white matter degradation in AD. An
important extension of this theory is to understand how white matter disconnection affects brain function in
both healthy aging and AD. However, the examination of age- and AD-related differences in white matter
connectivity, and its relation to brain function, is constrained by the relatively low resolution of standard DWI
data, which cannot accurately resolve fine-grained white matter regions with crossing fiber bundles or high
curvature. To address these limitations, this proposal will capitalize on a high-resolution multi-shot DWI
protocol that achieves spatial resolutions ≤ 1 mm3 on clinical 3T MRI scanners. Several studies of rodents and
younger adults already suggest that high-resolution DWI estimates white matter structural connectivity more
accurately than standard resolution DWI. This proposal will translate this earlier work by examining whether
standard (1.5 mm3 voxels; 3.375 𝜇l volume) and high-resolution (1 mm3; 1𝜇l volume) measures of white matter
structural connectivity differ in their relations to age and ability to explain age-related differences in cognitive
performance (Aim 1) or functional connectivity (Aim 2) in healthy adults across the lifespan (n = 140; ages 18-
80 years). This proposal will also examine the sensitivity of high-resolution DWI to white matter disconnection
and aberrant structure-function relations in adults with AD (n = 30; Aim 3). Cognition in the healthy adults will
be assessed using 12 tests of memory, executive function, and perceptual-motor speed. Structural (DWI) and
functional (resting-state functional MRI) connectivity will be assessed using a graph theoretical approach,
providing a novel basis for comparison between these different MRI modalities. Results from this clinically
feasible high-resolution DWI protocol will help answer fundamental questions about relations between
neurocognitive aging, brain structure, and brain function, which is important as the field is moving toward large-
scale, multimodal datasets. Ultimately, this project may identify additional age- and AD-related differences in
white matter connectivity that cannot be identified using only standard resolution DWI and may inform future
interventions targeting white matter connectivity to slow atypical cognitive decline. The wealth of neuroimaging
and aging resources available to the applicant at Duke University Medical Center will help her establish an
independent research program focused on multiple cognitive domains, graph theory, and advanced DWI
methodology, thereby propelling her toward her career goal of becoming a professor at a four-year university.

Public health relevance
PROJECT NARRATIVE Declines in attention and memory are a hallmark feature of Alzheimer’s disease, but some degree of cognitive decline is also evident in healthy older adults. This project will assess whether brain connectivity assessed by high-resolution relative to standard resolution diffusion-weighted imaging is more sensitive to both normal age- related cognitive decline and Alzheimer’s disease. Ultimately, results may assist with the early identification of adults who are at heightened risk for atypical cognitive decline and will set the stage for studies that may wish to use this clinically feasible high-resolution magnetic resonance imaging protocol in future aging research.